Developmental Research Program

The goal of the Developmental Research Program is to identify and support high quality, conceptually innovative translational projects that are not yet mature for full program status despite having outstanding potential. The Developmental Research Program will facilitate the attainment of this objective by 1) coordinating developmental research project selection 2) fostering the success of these projects through monitoring of their progress and 3) establishing institutional and extramural collaborations. Moreover, at the discretion of the Executive Committee of the SPORE, pilot projects which generate promising results can replace SPORE research projects which become funded as independent R01 or POI's projects and replace research projects which fail to show satisfactory progress. The long term goal of the Lymphoma SPORE program is to translate the findings generated by the Developmental Projects into a reduction of the incidence, morbidity and mortality of lymphoma. Specifically, the Developmental Research Program will; 1. Encourage innovative laboratory, population, and clinical studies with translational relevance by providing seed money to investigators 2. Support the evolution of developmental projects by providing intellectual and practical feedback through critical review and monitoring 3. Encourage intra-institutional and extramural collaborations between basic, clinical and population sciences with impact on translational research in lymphoma 4. Contribute to the overall success of the SPORE by providing the Executive Committee with guidance regarding promising projects in City of Hope's lymphoma translational research pipeline

Public health relevance
The goal of the Developmental Research Program is to identify and support high quality, conceptually innovative translational projects that are not yet mature for full program status despite having outstanding potential.